Core C: Prevention and Implementation Sciences Core

PROJECT SUMMARY/ABSTRACT
The Prevention and Implementation Sciences (PAIS) Core (Core C) is dedicated to supporting rigorous,
high-impact team science and accelerating the highest caliber HIV prevention, behavioral science, and
implementation science research in support of NIH research priorities and the Ending the HIV Epidemic
Initiative (EHE). In the current funding cycle, PAIS developed a successful service center model, launched the
Study Management and RetenTion System (SMART) study platform, and co-developed the Planning for
Success grant writing initiative. The PAIS Core will continue these successful initiatives and will develop new
services to advance prevention science objectives. A goal of the Core is to provide training and support in
implementation science to bridge implementation chasms that impede progress toward reaching the EHE
goals. The proposed Aims expand beyond traditional sociobehavioral sciences to integrate novel technologies
(e.g., mHealth), theoretical advancements (e.g., implementation frameworks), and web-based platforms for
service provision. Collectively, these expansions will enhance the Core's impact and promote the CFAR priority
of conducting groundbreaking, transdisciplinary science.
mHealth and implementation science approaches, grounded in sociobehavioral sciences, offer promising
avenues to achieve EHE and NIH research priorities by supporting scale-up of successful interventions. Given
EHE's ambitious goals, scaling-up evidence-based interventions (e.g., PrEP, HIV testing) through traditional
physical access channels and in-person interventions will be challenging. mHealth approaches provide rapidly
scalable solutions, and all Emory CFAR Members will benefit from the Core's apps and survey support
services that shorten the time from concept to funded research. Implementation Science approaches offer
critical frameworks and methods to elucidate the determinants of implementation, and to scale-up mHealth and
other efficacious approaches vital to achieving EHE goals. They also hold great promise for achieving health
equity by facilitating uptake of efficacious interventions among structurally marginalized populations. A new
training program, Collaboration for Success (CfS), will make PAIS Core services more accessible through a
series of virtual and in-person meetings and by making datasets available to facilitate novel research and to
strengthen grant applications. Building on the Core's strengths in sociobehavioral science methods and in
collaboration with CFAR Cores and SWGs, the PAIS Core will support rigorous transdisciplinary HIV research
through the following specific aims.
Aim 1. Facilitate cutting-edge technology-based HIV prevention and implementation science research.
Aim 2. Support the rigorous application of IS approaches in CFAR and NIH proposals and research.
Aim 3. Enhance access to sociobehavioral and biomedical HIV prevention research resources.